Discerning L-type trafficking modulation by targeted excision of ubiquitin and SUMO

PROJECT SUMMARY
The enclosed application outlines the research and career development plans designed to facilitate the
successful transition of the principal investigator, Dr. Sri Karthika Shanmugam, to an independent academic
position through the K99/R00 award. Dr. Shanmugam has a multidisciplinary background, and through this
K99/R00 proposal, seeks to finalize her cardiovascular training, master the biology of a new regulatory system,
and gain skills for her career as an independent investigator.
The K99 phase of this award involves a structured career development plan that will allow Dr. Shanmugam to:
advance her skills in cardiac contractility experiments on the cellular level using freshly isolated murine myocytes
as well as in vivo experiments on the organism level by echocardiography; gain essential training in SUMO-
based trafficking and functional experiments; and acquire important career skills such as grant writing, science
communication, lab management, teaching and mentorship, responsible conduct of research, and mastery of
the academic job application process. The career development plan also includes clear and actionable steps for
identifying and successfully obtaining an independent tenure-track faculty position by the end of the K99 phase.
Dr. Shanmugam has assembled a top-tier team of multi-disciplinary mentors, advisors, and collaborators that
will oversee and guide her training, research program, and transition to independence.
The research program for the K99 phase focuses on mechanistic and functional studies of the cardiac L-type
CaV1.2 trafficking regulation mediated by enDUBs that are designed to excise specific ubiquitin linkage chains
from the channel. The R00 research program then aims to employ the mechanistic information and technical
skills gained in the K99 phase to study novel CaV1.2 trafficking regulatory pathways modulated by SUMO and
SUMO-ubiquitin signaling crosstalk. Core research questions addressed include: What is the role of ubiquitin
and SUMO in regulating CaV1.2 channel forward and reverse trafficking? What are the molecular determinants
of these regulatory mechanisms? How do these mechanisms impact cardiac function?
To answer these questions, Dr. Shanmugam has formed a comprehensive research plan combining state-of-
the-art technology including flow-cytometry, digly-proteomics, ion channel electrophysiology, membrane protein
biochemistry and cellular biology. It involves the detailed study of trafficking dynamics and function of CaV1.2
channels; interrogation of the link between ubiquitin and SUMO; and evaluating cardioprotective abilities of
enDUBs using a heart failure model. This research will provide key insights into CaV1.2 trafficking mechanisms
mediated by ubiquitin and SUMO in the heart, which will accelerate targeted treatments for heart diseases.
The proposed studies will take place at Columbia University, which is abode to a vibrant community of
physiologists, biophysicists, and biochemists. This environment is ideal to promote the successful completion of
Dr. Shanmugam’s proposed K99 research program and transition into an independent researcher.

Public health relevance
PROJECT NARRATIVE A better understanding of normal cardiac physiology and pathophysiology is necessary to develop novel therapeutics against heart disease, which is the leading cause of mortality in the United States. Heart rhythm relies on the faithful positioning of L-type channels at heart cell surface as derangement is linked to severe disorders including ventricular arrythmias and heart failure. The proposed research will elucidate molecular mechanisms underlying surface trafficking and functional regulation of cardiac L-type channels, and bridge mechanistic insights to advance the development of targeted therapeutics for heart diseases.